New Approaches to Modeling and Targeting Cyclin E-amplified High-Grade Serous Tubo-Ovarian Carcinoma

Project Summary
Nearly all ovarian cancer deaths result from platinum-resistant high-grade serous tubo-ovarian carcinoma
(HGSC), which typically responds poorly to PARP inhibitors, other “targeted therapies,” conventional
chemotherapy, and/or immune checkpoint blockade. Approximately 20% of HGSC is driven by CCNE1
amplification (CCNE1amp), which almost always leads to platinum resistance. This MPI application joins experts
in cancer biology/signal transduction/mouse modeling (NEEL) and HGSC genomics/therapeutics (LEVINE)
with the overall objective of improving treatment of this poorly responsive subgroup. We contend that achieving
this goal will require detailed analysis of sophisticated, genetically informed, immune-competent models of
CCNE1amp HGSC. To this end, we developed a novel, mouse fallopian tube epithelial (FTE) organoid platform
that can be used for rapid modeling of combinations of the genetic defects seen in human HGSC, as well as
organoid and patient-derived xenograft (PDX) models of normal FTE and human CCNE1amp HGSC. In work
under review, we found that Brca1-deleted, Ccne1-overexpressing (Ccne1OE), and Pten/Nf1-deleted FTE
organoids differ in proliferation/differentiation, cytokine/chemokine secretion, and drug response in vitro, and
evoke tumors with distinct kinetics, transcriptomes, and tumor immune microenvironments (TMEs) upon
orthotopic injection (ovarian bursa) into syngeneic mice. Based on this information, we devised a chemo-
immunotherapy regimen that yields T cell-dependent, durable, apparently curative, complete responses (CR) in
a highly aggressive Tp53-/-;Ccne1OE;Akt2OE;KrasOE HGSC model. We now propose to: (i) clarify the mechanistic
of efficacy of this combination regimen, (b) determine the effects of other mutational events that co-occur
frequently with CCNE1amp on the phenotype of Tp53-/-;Ccne1OE FTE in vitro and in vivo, including whether our
combination regimen is broadly efficacious in Ccne1OE HGSC, and (c) assess the relevance of these findings in
human organoid and PDX models of CCNE1amp HGSC.

Public health relevance
Relevance: HGSC is the most lethal form of ovarian cancer and remains largely incurable. CCNE1amp HGSC has a particularly poor prognosis, as it fails to respond to platinum-based therapy. By developing and characterizing sophisticated new mouse and human models of CCNE1amp HGSC, we hope to develop new therapeutic strategies for this deadly disease.